A Rabbit Model of Epstein-Barr Virus Infection

PROJECT SUMMARY
Epstein-Barr virus (EBV) is a herpesvirus that persists as a notable human pathogen with significant
oncogenic potential that is related to its ability to establish lifelong latent infection within an immunocompetent
host. Unlike for the vast majority of viruses, EBV-associated diseases are almost exclusively a consequence of
latent infection instead of damage caused by virus replication. Latency poses significant problems, for example,
in the development of effective anti-EBV therapeutics, since the majority of such compounds are designed to
target viral polymerases and other proteins active only during virus replication; novel approaches are therefore
needed to target latent EBV infection. Moreover, the ubiquitous nature of EBV (~95% infected by adulthood) and
the highly evolved equilibrium that it has established within the human immune system, make development of
an effective vaccine challenging. Both of these challenges could be greatly aided by a biologically accurate and
tractable animal model of EBV infection, which currently does not exist. Surprisingly, several reports over the
last decade have provided support for the laboratory rabbit as a model of EBV infection. In preliminary work, we
have confirmed the most salient observations from these earlier studies, confirming that rabbits are indeed
infectable, as indicated by persistence of the viral genome and expression of EBV genes associated with both
the latent and productive stages of the virus lifecycle. However, several critical demonstrations are required to
support authenticity of this model, and thus the extent to which it could be applied experimentally. In this
application, we propose three specific aims to fill these gaps through complementary efforts by two senior
investigators in the EBV field, and a third who has considerable expertise in the use of the rabbit as a model for
virus infection and immune-related studies. Under Aim 1, Dr. Clare Sample will assess EBV infection in the
epithelial cell component of the lifecycle, including the use of organotypic (raft) cultures of primary epithelium, a
model she has developed and used to define EBV infection in human epithelium. Under Aim 2, Dr. Jeffery
Sample will employ his expertise in the field of EBV latency to direct studies to elucidate whether establishment
of a persistent infection in rabbit B cells is mechanistically comparable to the process that occurs in the human
B-cell compartment. Finally, Dr. Neil Christensen, employing his expertise with the rabbit model will support work
under Aims 1 and 2, and in Aim 3 will assess the humoral and cell-mediated immune responses to EBV infection
in the rabbit, and whether they are comparable to key aspects of the adaptive immune response to EBV infection
in the natural host. In summary, the proposed work will inform us whether the three basic host components that
dictate EBV biology in its human host are equivalently functional in the rabbit: 1) Whether rabbit epithelium
supports EBV replication that is critical for passage of the virus onto a naïve host; 2) Whether persistence of
EBV in rabbit B cells is established through an authentic latent infection; and 3) Whether a comparable adaptive
immune response is mounted to EBV infection in the rabbit.

Public health relevance
RELEVANCE The lack of a biologically accurate and tractable animal model of Epstein-Barr virus (EBV) infection has long hampered efforts to fully understand the complex lifecycle of this potentially oncogenic human herpesvirus, and for the development of anti-viral drugs and vaccines with which to treat or prevent EBV-associated disease. The proposed research seeks to expand on previous work supporting the laboratory rabbit as such a model of EBV infection, critically assessing whether key components of EBV infection in its human host are recapitulated in the rabbit, and thus validating the utility of this animal model.